Education & Training

The Center will allocate $109,067 to the Education and Training Unit. From these funds, an allocation of $6,300 will be made to establish a unique semester-long course within the PS-OC, including a webcast for an external audience, entitled, Evolutionary Systems Biology of Cancer. Another $13,700 will be allocated to an external Seminar Series, and $20,000 will fund a small collaborative Retreat for PS-OC team members. A year-long post-doctoral training program inclusive of post-doctoral fellows participating in PSOC projects and the Core (funded as part of project 1,2,3, or Core) will be organized, and $50,000 will be allocated for a visiting investigator exchange program to exchange post-docs, junior and senior investigators among the larger PS-OC network.

Public health relevance
The education and training programs of the PS-OC will ensure that the staff of the PS-OC is well trained, that the knowledge generated within the Center is available to other interested parties, and that evolutionary theory of cancer becomes accepted as a field of its own.